Advanced Testing in Omics using Mass Spectrometry (ATOMS)

Project Summary – Metabolism and Metabolomics Core
The purpose of the Metabolism and Metabolomics Core is to encourage and facilitate use of targeted and
untargeted analytical methods for nutritional epidemiological and intervention studies, to provide access to
state-of-the-art techniques and equipment to bench scientists, and to provide cost-effective assays for
investigators without lab facilities. The Core was established in 1999 under the leadership of Dr. Steven Zeisel.
Dr. Susan Sumner joined UNC in 2017 and took on the leadership of the Core. The Core specializes in using
state-of-the-art metabolomics and exposome technologies to determine how molecules that are present in
cells, tissues, and biological fluids are associated with weight status, nutrient status, and states of health and
wellness. The measurement of perturbations in metabolism that arise from disease, dysfunction, or exposure
(e.g., chemicals, drugs, nutrients, foods, stress) is referred to as metabolomics. The measurement of all
exposures and the impact on endogenous metabolism is referred to as the exposome. Metabolomics is an
ideal approach to assess the impact of nutrition and diet on health because individuals have different nutrient
requirements and individuals respond differently to nutrient intake and diet and exercise interventions. The
Core also provides metals assays and quantitative targeted analysis of metabolites involved in one carbon
metabolism for nutrition and obesity studies. The Core’s services are unique and do not overlap with the North
Carolina Translational and Clinical Sciences Institute (NC TraCS) or other UNC core services. The Core offers
services and equipment at both the Chapel Hill campus and the UNC Nutrition Research Institute campus (two
hours from Chapel Hill in Kannapolis, NC) to make use of unique equipment and to broaden access to services
for both UNC NORC members and external users.